Neuro-Immune mechanisms against skin-penetrating helminths

Neuro-immune mechanisms against skin-penetrating helminths
Summary
Diverse helminth species establish host infection through direct skin penetration, but the mechanisms of
cutaneous immunity are poorly understood. Curiously, percutaneous infection of over 250 million people with the
water-borne blood fluke Schistosoma mansoni often goes unnoticed and most of these individuals experience
frequent re-infection due to poor immune responses to skin-penetrating larvae. Whether a mechanistic link exists
between impaired protective immunity and failure of skin afferent neurons to release immunostimulatory factors
is a major gap in our current understanding of host immunity. Moreover, the role of the alarmin cytokine
interleukin 33 (IL-33) in driving host resistance or susceptibility to skin penetration by helminth larvae has not
been tested. Our data reveal that pre-emptive activation of mouse skin-afferents drives innate resistance to
parasite invasion accompanied by the recruitment of interleukin (IL)-17-producing CD4 and gd T cell subsets,
and inflammatory monocytes. Surprisingly, skin neuron activation also rapidly depletes IL-33 in tissue
macrophages and type 2 conventional dendritic cells (cDC2), but not skin fibroblasts. Indeed, mice with a genetic
deletion of IL-33 only in CD11c+ myeloid antigen presenting cells (APC) phenocopy host immune responses in
wild-type mice with activated skin-sensory neurons. This project seeks to identify the specific neuron subsets
and the soluble mediators they release that drive host resistance and discern whether such protection requires
loss of myeloid-specific IL-33. One of the key immunoregulatory neuropeptides released by skin afferents is
calcitonin gene-related peptide (CGRP) and our data show that CGRP administration results in myeloid APC-
intrinsic loss of IL-33 through unknown mechanism(s). Therefore, our central hypothesis that itch-responsive
skin neurons initiate host resistance to skin penetrating helminths via CGRP-mediated reduction of
myeloid-specific IL-33, which initiates production of IL-17-promoting cytokines from skin macrophage
and cDC subsets. The two specific aims of this proposal are to: (1) Identify the neuron subsets necessary and
sufficient for skin resistance to helminth infection and (2) determine how CGRP causes decrease in myeloid-
specific IL-33 and host resistance to parasite invasion. Successful completion of this project designed to
understand how sensory neuron-APC interactions control host protection and IL-33 expression stands to provide
key insight(s) for developing preventative measures against helminth skin penetration in humans, which do not
currently exist.

Public health relevance
PROJECT NARRATIVE The goal of these studies is to understand how sensory nerves in the skin regulate immune cell function during skin penetration by parasitic worms found in contaminated water. We think that protective immunity against these worms may be dependent on interactions between itch-specific nerves and immune cells in the skin, but this has not been studied before. The proposed experiments may uncover a therapeutic means to prevent skin penetration, which does not currently exist.